Training in Etiology and Consequences of Alcohol Use Across the Lifespan

Abstract
This T32 application seeks support for four postdoctoral lines at the newly established Rutgers Addiction
Research Center (RARC), the largest comprehensive addiction research center in the U.S, to provide training
in the etiology and consequences of alcohol involvement across the lifespan. The interdisciplinary training
program will be led by a core team of 11 RARC-affiliated faculty mentors across a number of academic
departments and centers at Rutgers who have active NIH funding portfolios and successful mentoring
histories. Additional expertise will be provided by a group of 9 supporting faculty from RARC who are domain
experts in related topics and/or methodological/ statistical experts. Faculty mentors contribute expertise in
course of alcohol use across the lifespan, the underlying biological mechanisms (e.g., stress hormones,
genetics, neurobiological) and psychosocial mechanisms (e.g., psychological, inter-personal, environmental),
and ensuing consequences. Specific faculty expertise in related conditions include trauma/PTSD, mental and
physical health, behavioral addictions including gambling and gaming, co-use of multiple substances, stress,
sleep, and women’s health. Trainees will be able to customize advanced methodologic training specific to their
research training goals across the areas of genomic analyses, longitudinal and intensive longitudinal analysis,
digital health, community-based research, treatment implementation, and intervention design. An Internal
Advisory Committee of five leaders at Rutgers and an External Advisory Board of four world-class researchers
with substantial knowledge in alcohol research training and experience fostering the integration of diversity
scholarship and alcohol research will monitor progress and provide guidance and recommendations. The
training program will consist of a two-year sequence of mentored and didactic experiences and individually
tailored professional development activities. Training includes hands-on mentored research with a primary
mentor supported by a mentoring team as well as engagement in a faculty-led core seminar series, a grant
writing sequence culminating in submission of an independent grant, journal clubs, and professional
development panels, as well as trainee research talks and external speakers at an in-person retreat. First-year
trainees will receive specialized training in state-of-the-art methodology, data analysis, and data science;
diversity, equity, inclusion, and accessibility; and responsible conduct of research including practices to
enhance research rigor and transparency. The program will host communication skills, mentorship training, and
career development events and will support a strong scientific community through work-in-progress and shared
interest groups and near-peer mentors. Finally, training faculty will receive mentorship training. Evaluation of
individual trainees, faculty mentors, and the training program will be based on formal benchmarks. This training
grant will launch the scientific careers of the next generation of alcohol researchers through interdisciplinary
alcohol training in an untapped, rigorous, and highly resourced addiction research environment.

Public health relevance
Project Narrative This T32 alcohol research training grant will provide diverse post-doctoral trainees with the knowledge and skills to develop expertise in the etiology and outcomes of alcohol involvement across the lifespan. Trainees will receive training in state-of-the art methods to understand the biological and psychosocial mechanisms underlying alcohol use and related problems with a cadre of training faculty with a strong history of mentoring and funded research, continually emphasizing research ethics as well as training in scientific rigor and reproducibility. The program would launch a new line of alcohol training in a highly resourced interdisciplinary addiction research community at the new Rutgers Addiction Research Center (RARC) and will ultimately reduce the burden of addiction and improve lives.